Endocannabinoid Modulation of the HIV-Induced Microglial Inflammatory Response

PROJECT SUMMARY/ABSTRACT
People living with HIV experience neurologic dysfunction, including encephalitis, depression, anxiety, and
cognitive deficits. Chronic inflammation is a major hallmark of HIV disease today and contributes to the
development of neurologic dysfunction in up to 50% of people living with the virus. These neurologic deficits
result in poorer daily functioning, decreased quality of life, and have become more prevalent due to the survival
benefits of antiretroviral therapy (ART). Thus, chronic inflammation and its consequent effect on neurologic
health represents a major public health issue. Microglia are an integral underlying mediator of this chronic
inflammation through production of inflammatory cytokines, chemokines, and antiviral responses. Together,
these components promote neuroinflammation that persists despite ART and contributes to neurologic
impairment through demyelination, pruning, and destruction of neurons. There is a pressing need to develop
adjunct therapies to limit deleterious effects on neurologic health. Cannabinoids are emerging as an important
modulator of inflammation. Phytocannabinoids, including cannabidiol (CBD), are known to modulate
inflammation through activation of canonical and extended endocannabinoid system receptors. While
canonical endocannabinoid receptors (CB1 and CB2) are the most well studied, less studied extended
endocannabinoid receptors (TRPV2 and PPAR-a) also possess immune modulating functions. The research
goal of this F31 proposal is to evaluate expression, function, and immunomodulatory potential of
endocannabinoid receptors, and CBD, in microglia in the context of HIV. Our preliminary data determine that
macrophage/microglia express both canonical and extended endocannabinoid receptors. Of note, they express
TRPV2 and PPAR-a more than any other brain cell type, including neurons, astrocytes, endothelial cells, and
pericytes. We determined that endocannabinoid receptor pharmacologic agonists modulate myeloid cell
inflammation following exposure to potent bacterial moiety, lipopolysaccharide, an example of a strong
inflammatory agent. Together, these preliminary data suggest endocannabinoid receptors are present on
myeloid cells and have the capacity to modulate chronic, myeloid derived inflammation. We hypothesize that 1)
CB1, CB2, TRPV2, and PPAR-a are present on macrophage/microglia, are selectively impacted by HIV
infection, and that they 2) mechanistically contribute to modulation of HIV inflammatory responses. We will
systematically test this hypothesis by evaluating the impact of HIV on expression and function of these
receptors. We will also use CBD and agonists to evaluate the mechanistic contribution of receptors to
modulating microglial inflammation. Successful completion of these research goals along with the proposed
mentorship and training provided through this F31 award will propel me forward in accomplishing my long-term
goal of becoming a public health research scientist working at the intersection of HIV and substance use.

Public health relevance
PROJECT NARRATIVE Microglia mediate chronic neuroinflammation during HIV that contributes to the development of neurologic dysfunction in up to 50% of people living with the virus, which is a major public health issue. We propose to leverage the anti-inflammatory potential of the endocannabinoid system, through pharmacologic agonists and the phytocannabinoid cannabidiol, to suppress this deleterious response in HIV-infected and uninfected microglia. Coupled with my mentorship and training goals, successful completion of these activities will propel me forward in accomplishing my long-term goal of becoming a public health research scientist working at the intersection of HIV and substance use.